Administration, patient recruitment, methods, informatics

The Core of this Program Project consists of four components that represent services that are provided to each of the three research projects. In addition, each of these components will continue to be engaged in development of the infrastructure required for the implementation of the methods in the research plan. The four components of the core described below are: 1. Administrative services 2. Neurological patient and subject recruitment support and development 3. Neuroscientific method support and development 4. Informatics and datacenter support and development.